A precision functional neuroimaging platform to enable collection of highly-sampled data at home

PROJECT SUMMARY
The goal of this Phase I STTR is to enable the commercial readiness of an imaging platform for precision
mental health. Despite significant federal investment, the translation of functional brain imaging technologies
into clinical psychiatry remains elusive. Current methods, such as functional Magnetic Resonance Imaging
(fMRI) and Electroencephalography (EEG), show poor reliability and reproducibility, in large part due to
reliance on group-averaging and short-duration recordings. Accumulating evidence suggests that larger
quantities and durations (i.e., highly sampled) of data are needed to fulfill the promise of functional
neuroimaging in clinical psychiatry. Objective, highly reproducible measurements of brain function would
empower clinicians and researchers to make more accurate characterization of mental illnesses and reliable
monitoring of treatment efficacy. One way to meet the need for highly sampled data collection is to enable data
collection by patients themselves or their parents/caregivers, out of the lab (e.g., at home), similar to at-home
blood pressure monitoring. Unfortunately, current methods cannot scale because they are too costly and
impractical. To this end, our interinstitutional, multidisciplinary team of experts in engineering, neuroscience,
psychiatry, UX and software design has developed a functional prototype of a precision mental health platform
appropriate for at-home use. The prototype integrates a low-cost, wireless, multi-sensor, wearable functional
near infrared spectroscopy (fNIRS) device with a tablet app that delivers standard, neuroimaging-ready
cognitive tests through a HIPAA-compliant cloud portal for researchers and clinicians to remotely monitor
patient’s brain response during long sessions spanning multiple days or weeks. Importantly, our platform’s
unique strategy for self-alignment and ultra-low cost are key features to enable scalable, at-home use by
patients with high data accuracy. In contrast, hurdles of cost and usability limit scalability for at-home use of
other commercial and emerging fNIRS systems, which are largely designed for use by researchers. Our
preliminary study to collect highly sampled data in a small cohort of healthy adults in a home-like setting with
our prototype showed (1) data reliability improves significantly with longitudinal use and (2) we can extract
robust and reproducible individual- and group-level findings. In preparation for commercialization, this proposal
aims to overcome two technical hurdles needed to ensure reliability of the data collected by patients at home:
(Aim 1) Modify the prototype design for reliable data acquisition across inclusive physical differences such as
varying head size and skin tone; (Aim 2) Evaluate the feasibility and usability of the developed platform in an
at-home study. While our system is generalizable for a variety of illnesses and disorders, here we will validate
its clinical relevance for attention deficit hyperactivity disorder (ADHD), a model disorder due to its clinical high
significance, brain target accessibility and ease of recruitment. If successful, our Phase II proposal will aim to
modify the device for scalable manufacturability and carry out larger clinical validation studies.

Public health relevance
PROJECT NARRATIVE Mental illness presents significant challenges in diagnosis and treatment, but current tools are inadequate to collect the data needed to reliably understand underlying brain mechanisms and accurately assess individual- and group-level differences. Our team has developed a low-cost, non-invasive, wearable device that can be used in at-home environments to enable new clinical studies that collect long-duration recordings of brain activity. This Phase I STTR proposal focuses on overcoming technical hurdles to progress towards commercialization and to ensure the reliability of data collected with the prototype and usability in an at-home context.